From Workforce Diversity to Key Cultural Competency Strategies to End Racial Disparities in Opioid Treatment Outcomes Across the Nation

PROJECT SUMMARY/ABSTRACT
In response to PAR-18-747, Addressing the Challenges of the Opioid Epidemic in Minority Health and Health
Disparities Research in the U.S. (R01), this study seeks to determine the role of culturally competent
strategies, and in particular workforce diversity, to improve treatment access, engagement, and medication-
assisted treatment (MAT) maintenance dosage, i.e., methadone, buprenorphine and naltrexone for African-
American and Hispanic populations in opioid treatment programs (OTP) nationwide. The study will rely on the
National Drug Abuse Treatment System Survey (NDATSS), which is a unique, nationally representative
longitudinal data (2005-2017); the study also will collect two waves of new data in 2021 and 2023 to assess the
effect of culturally and linguistically appropriate services (CLAS) on OTP process measures [wait time,
retention, and adequate MAT dosages). The study seeks to improve measurement of cultural competence
using a gold standard instrument - the Cultural Competency Organizational Assessment (COA360 [CLAS]) and
assess its predictive validity on process measures in 2021 and 2023. Findings will inform treatment programs’
use of cultural competency strategies to improve OTP wait time, retention and adequate dosage, and with
these efforts reduce racial/ethnic disparities in opioid use disorder treatment. Policy-makers will be able to
make decisions about how to allocate scarce resources needed to address the opioid epidemic.

Public health relevance
PROJECT NARRATIVE In response to PAR-18-747, Addressing the Challenges of the Opioid Epidemic in Minority Health and Health Disparities Research in the U.S. (R01), we will analyze the role of culturally competent strategies, and in particular workforce diversity, in improving treatment access, engagement, and medication-assisted treatment (MAT) maintenance dosage, i.e., methadone, buprenorphine and naltrexone, for African-American and Hispanic populations in opioid treatment programs (OTP) nationwide.